Core 3: Biostatistics and Bioinformatics Core

CORE 3_BIOSTATISTICS AND BIOINFORMATICS: ABSTRACT
The Biostatistics and Bioinformatics Core (Core 3) provides essential data management, statistical analysis, and bioinformatics support for the SPORE, with a focus on enabling cost-effective, high-dimensional data analysis and integration. Core 3 will manage and analyze complex multimodal datasets, including biological, clinical, pathology, genomic, and imaging data, to support all SPORE Projects as well as the Career Enhancement and Developmental Research Programs. Core 3 operates through a collaborative partnership between Weill Cornell Medicine (WCM) and MD Anderson Cancer Center, leveraging the established infrastructure and institutional resources at both institutions to provide HIPAA-compliant data handling and advanced next-generation sequencing (NGS) pipelines. The Core 3 team brings comprehensive expertise in genomics, biostatistics, and the management of large-scale datasets from both clinical and basic science research projects. This partnership ensures comprehensive support for the SPORE projects, guiding the transition of basic science findings to clinical applications. Core 3 will utilize state-of-the-art, high-throughput sequencing technologies to analyze samples from patients, animal models, and cell lines; apply integrative bioinformatic and biostatistical approaches to extract biological insights from multi-platform datasets; and supervise design, data collection, and data analyses of all experiments and clinical trials. Core 3 will provide a suite of analytical tools for the SPORE projects, including methods for analyzing continuous and categorical response variables, repeated measures, survival data, and exploratory analyses. Core 3 will handle missing data, perform sample size and power calculations, and ensure corrections for multiple testing. Furthermore, Core 3 will develop novel algorithms where necessary, especially for high-dimensional data integration, thus accelerating the identification of biomarkers and translational research outcomes. Across SPORE Projects, Core 3 will ensure thorough documentation of all data and analysis steps to guarantee rigorous and reproducible results. Core 3 will guide the integrative analysis of complex data, manage its release to public and controlled repositories, and establish a Lymphoma Data Portal to facilitate broader access for both SPORE investigators and the wider research community. To promote ethical, transparent and collaborative research, Core 3 will collaborate with all other SPORE Cores to ensure seamless data access, sharing and integration. With decades of experience in processing and analyzing multidimensional datasets for team science initiatives, Core 3 is positioned to drive impactful discoveries and enhance the overall research mission of the SPORE.

Public health relevance
The Biostatistics and Bioinformatics Core (Core 3) supports all SPORE Projects by managing, analyzing, and integrating complex, multimodal data sets, including clinical, genomic, imaging and pathology data. Core 3 provides HIPAA-compliant data handling, advanced NGS pipelines, and expert statistical and bioinformatics analysis to ensure rigorous, reproducible, and translational research. It will also develop novel algorithms, guide data sharing and collaborate across Cores to accelerate biomarker discovery and improve lymphoma outcomes.